A Digital Patient Decision Aid to Increase Sexually Transmitted Infection Testing in the Emergency Department: The STIckER Study

ABSTRACT
Improved screening for sexually transmitted infections (STI) is essential to reversing the STI epidemic in the
United States (US). Nearly half of STIs in the US occur in adolescent and young adults (AYA) aged 15-24, and
failure to perform genitourinary and extra-genital (anorectal and oropharyngeal) STI testing contributes to the
propagation of disease. Emergency Departments (ED) care for over 17 million AYA each year, the majority being
poor and minority. Our prior work demonstrated the inconsistent use of contraceptives among this population,
and how, although ED providers are receptive to ED-based sexual health interventions, implementation barriers
persist, such as limited time and resources. Innovative interventions are needed that fit efficiently within the ED
workflow and maximize appropriate STI testing. One such intervention would be a patient decision aid that
informs and empowers AYA patients who may benefit from STI testing. Patient decision aids have been used to
successfully facilitate shared decision-making in the ED for various clinical scenarios. We have gathered a multi-
disciplinary team of experts in pediatric, adult, and emergency medicine, ED-based clinical trials, digital health,
implementation science, biostatistics, and shared decision-making to develop STIckER (STI ChecK in the ER),
an evidence-based, digital patient decision aid to facilitate STI testing in the ED using a shared decision-making
approach. STIckER consists of three steps: (1) the patient “scanning the sticker” via a QR code leading to a non-
judgmental sexual health screening assessment; (2) shared decision-making educational modules connecting
personalized STI risk to evidence-based testing recommendations; and (3) facilitation of a patient-provider STI
testing conversation using a confidential, color-coded digital infographic. The specific aims of this proposal are
(1) To refine “STIckER,” our STI testing patient decision aid through an iterative development approach based
on stakeholder feedback; (2) To conduct usability testing and finalize development of STIckER; and (3) To
conduct a pilot randomized trial to examine the preliminary efficacy and implementation of STIckER in the ED.
We hypothesize that sexually active AYA who interact with STIckER will more often undergo any STI testing
compared with sexually active AYA who do not interact with STIckER. SIGINIFICANCE: An effective, automated
digital intervention increasing STI testing can be utilized in other EDs as a reproducible means to promote the
provision of evidence-based sexual health education, decrease STI rates, and improve AYA health outcomes
throughout the US.

Public health relevance
NARRATIVE Sexually transmitted infections (STIs) in the United States remain a national concern, disproportionately affecting adolescent and young adults, many of whom frequently use the emergency department (ED) for their medical care. EDs must implement innovative, patient-centered STI screening strategies that are reproducible, evidence-based, and increase STI testing among this underserved population. This research will refine and test a digital patient decision aid, entitled STIckER (STI Check in the ER), that aims to facilitate shared decision-making and increase STI testing among adolescent and young adult ED patients, as well as support the NIH research mission to develop effective prevention approaches to control STIs.